Multi-ethnic Observational Study in American Asian and Pacific Islander Communities (MOSAAIC) Administrative Supplement

Project Summary
The new Multi-ethnic Observational Study in American Asian and Pacific Islander Communities (MOSAAIC)
cohort represents a pioneering longitudinal study designed to make substantial contributions to our
understanding of the health and health disparities within populations of Asian, Native Hawaiian, and Pacific
Oceanic ancestry. The overall objective of this study is to establish an epidemiologic cohort comprising a
minimum of 10,000 individuals aged 18-64, residing in the United States, who have Native Hawaiian ancestry
or affiliations with Asian nations (East, Southeast, or South) or Pacific Islands in their family heritage or place
of birth, and to examine the prevalence and incidence of cardiometabolic and mental health conditions and
their associated risk factors.
Within the first 6 months of initiation, the investigators have developed a functioning organizational structure
and through this, have drafted a core protocol. The key features of this protocol include a baseline survey
covering a broad range of topics, a brief physical exam (anthropometry, ECG, and spirometry) and
biospecimen collection (saliva, blood, urine, and stool). Follow-up at 6 months,12 months, and annually
thereafter will include health updates and additional exposure assessments. Selected health outcomes (e.g.,
myocardial infarction, stroke, heart failure) will be documented and adjudicated. To accommodate changes in
NHLBI requirements (expansion of age eligibility and country of origin groups), address gaps in the
understanding of protocol requirements, and the interests of the investigators in enhancing critical data, we
propose to: 1) Enhance participant recruitment and retention strategies with additional participant
recruitment and materials in official study languages and capitation payments associated with completed
follow-up contacts to assist with staffing costs of follow-up and medical record collection and to provide an
associated participant incentive; and to 2) Improve the quality and scientific rigor of study data, clinical
measures, and biospecimens though more in depth assessments (a second spirometry following
bronchodilation and linkage of culturally adapted nutritional assessments with nutrient databases), additional
standardization of ECG equipment and biospecimen supplies, the feasibility study of PBMC collection, and the
incorporation of a baseline repeatability study to assess the reliability of our novel data collection items. These
enhancements to the core study will strengthen the overall cohort and the inference that can be drawn from it.

Public health relevance
Project Narrative The efforts outlined will increase the likelihood of MOSAAIC cohort success in recruitment and retention and strengthen elements of the core protocol by expanding selected core data, ensuring greater standardization across sites, and assessing the reliability of the novel data collection.